Assessment of the Median Lethal Dose (LD50) of Nipah Virus via the Intranasal/ Intratracheal and Inhalational Routes of Exposure

To assess the virulence of Nipah Virus by the intranasal/intratracheal and inhalational routes of infection in an animal model.